Nck adaptor proteins in atherogenic endothelial activation

PROJECT SUMMARY
Alterations in hemodynamic shear stress at atherosclerosis-prone sites promotes endothelial activation,
characterized by nuclear factor-B (NF-B)-driven expression of cell adhesion molecules that mediate leukocyte
homing. In addition to flow patterns, proinflammatory cytokines (e.g. IL-1) promote NF-B-dependent
endothelial activation. While the recent CANTOS trial using an IL-1 antagonist highlights the potential for
treating atherogenic inflammation beyond lipid lowering therapies alone, our understanding of how endothelial
activation contributes to this effect remains limited. During the previous funding period, my laboratory identified
the signaling adaptor Nck1 as a critical regulator of atherogenic endothelial activation. Endothelial cells deficient
in Nck1 lack flow-induced NF-B activation and proinflammatory gene expression both in vitro and in vivo, and
domain swap experiments and point mutation analysis suggest a critical role for the Nck1 SH2 domain and the
first Nck1 SH3 domain in mediating these effects. To understand how Nck1 mediates atherogenic endothelial
activation, we isolated Nck1’s proinflammatory functions to the Nck1 SH2 domain and fist SH3 domain.
Additionally, we demonstrated an interaction between Nck1 and IL-1 signaling in response to disturbed flow,
showing that disturbed flow activates the IL-1 receptor (IL1R1) signaling partner IRAK-1 in a Nck1-dependent
manner both in vitro and in vivo. IRAK-1 depletion inhibited the proinflammatory response to disturbed flow, but
the mechanism by which disturbed flow stimulates IRAK-1 signaling remains unknown.
The Nck family of signaling adaptors (Nck1 and Nck2) play redundant roles during vascular development and
retinal neovascularization, with defects only observed when both isoforms are inhibited. Consistent with our cell
culture studies, global Nck1 knockout mice show reduced atherosclerosis characterized by diminished
macrophage and smooth muscle incorporation, whereas endothelial Nck2 knockouts do not. While bone marrow
chimeras suggest non-hematopoietic Nck1 mediates this response, questions concerning the relative roles of
endothelial and smooth muscle Nck1 in this response persist. A recent GWAS analysis linked Nck1 to coronary
artery disease, underscoring its importance to human disease. Therefore, we hypothesize that Nck1 adaptors
mediate the formation of IL-1-related signaling complexes to induce atherogenic endothelial activation, and
selective inhibition of Nck1 or its critical domains will allow efficient inhibition of atherogenic endothelial activation
without affecting ischemic vascular remodeling. We will determine the mechanisms by which Nck1 regulates
disturbed flow-induced IRAK-1 activation (Aim 1), characterize the interplay between Nck1 and IL-1-associated
signaling in disturbed flow-induced endothelial activation in vivo (Aim 2), and assess whether selective Nck1
inhibition differentially affects atherosclerosis and ischemic angiogenesis (Aim 3). Successful completion of
these aims will identify new mechanisms by which Nck1 mediates atherogenic endothelial activation and will
characterize Nck1 as a therapeutic target to limit atherosclerosis.

Public health relevance
PROJECT NARRATIVE Functional alterations in the endothelial cells lining the vessel wall represent an important step in atherosclerotic initiation, progression, and clinical complications. Our research identifies Nck1 and IRAK1 as novel players in this process, regulating proinflammatory gene expression in response to changes in the local microenvironment. Understanding the molecular mechanisms controlling endothelial cell function by the microenvironment may provide novel therapeutic targets to limit chronic inflammatory diseases, such as atherosclerosis and arthritis.